Retention and Re-Engagement in Treatment for Addiction following Serious Injection Related Infections (RETAIN)

PROJECT SUMMARY
Serious injection-related infections (SIRIs), including infective endocarditis, bacteremia, osteomyelitis, epidural
abscess, and septic arthritis have more than doubled since 2002 due to the opioid epidemic, causing morbidity,
mortality, and costing more than $700 million annually. Growing evidence suggests that medications for opioid
use disorder (MOUD) which include methadone, buprenorphine, and extended-release naltrexone reduce
readmission and death following SIRIs. In response to this emerging data, programs and studies seek to
optimize MOUD initiation in hospitals. However, the benefits of MOUD have not been fully realized due to
limited retention in treatment with MOUD after hospitalization. To date, there has been a paucity of research
focused on MOUD retention, the crucial next step of the opioid use disorder (OUD) care continuum. Further,
evidence-based MOUD retention interventions have not been adapted for individuals with SIRIs who have
riskier injection practices, greater medical complexity, mortality, and costs than others with OUD. The
Recovery Management Checkups model is a proactive, peer-delivered, motivational interviewing-based MOUD
retention intervention that increased retention by 50% in outpatient addition treatment and following
incarceration. It has been piloted in multiple settings, making it a promising intervention for individuals with
SIRIs who face unique challenges following their infections. Therefore, the central objective of this proposal is
to determine individual and group factors associated with MOUD treatment along the OUD care continuum in
the critical 12 month period after a SIRI and to use these insights to adapt and test Recovery Management
Checkups for this new population. This proposal includes three aims: 1) Examine MOUD treatment along the
OUD care continuum in the 12 months after SIRIs; 2) Informed by the findings from Aim 1, adapt the Recovery
Management Checkups MOUD retention model for individuals with SIRIs; 3) Conduct a pilot randomized
controlled trial of the adapted intervention to promote MOUD retention and re-engagement for individuals with
SIRIs. The findings from these Aims address a gap in current research and will inform care for individuals with
SIRIs, a priority area for the National Institute on Drug Abuse. Dr. Kimmel, an early-career investigator is the PI
and will use this Career Development Award to develop skills in modeling approaches to address recurrent
events (e.g. multiple treatment episodes) and group membership (e.g. latent classes) in treatment retention
data, qualitative methods, intervention adaptation and development, and clinical trials design. Developing
these skills will position him to lead impactful research that will improve the care and outcomes for very high-
risk individuals who use drugs. Dr. Kimmel will work closely with a mentorship and advisory team with
experience in addiction medicine, infectious diseases, biostatistics, qualitative methods, intervention adaptation
and development and clinical trials to accomplish his research and training Aims.

Public health relevance
PROJECT NARRATIVE Hospitalizations for serious injection-related infections may motivate individuals to seek treatment with medications for opioid use disorder which reduce mortality and re-hospitalization in this population. However, the benefits of medications for opioid use disorder are not fully realized for individuals with serious injection- related infections due to limited treatment retention. This Career Development Award will use insights from public health treatment data and qualitative interviews to systematically adapt and evaluate a medication for opioid use disorder retention intervention, Recovery Management Checkups, for individuals with serious injection-related infections. Simeon Kimmel, MD, MA